A multidisciplinary approach to understanding feedback and clustering in PCP signaling

Summary/Abstract
Planar cell polarity (PCP) signaling controls the polarization of cells within the plane of an epithelium, orienting
asymmetric cellular structures, cell divisions, and cell migration and is well conserved from Drosophila to
vertebrates. In vertebrates, defects in the core PCP mechanism result in a range of developmental anomalies
and diseases including conotruncal heart defects, open neural tube defects, deafness, and situs inversus and
heterotaxy, among others. Congenital heart disease (CHD) comprises close to half of all birth defects, and
conotruncal heart malformations are the most common CHDs in humans, and include anomalies such as
double outlet right ventricle, transposition of the great arteries, and overriding aorta. Despite its critical role in
the development of the heart and other organs, the molecular mechanisms that drive PCP signaling remain
remarkably poorly understood.
Although a mechanistic dissection of PCP signaling would be prohibitively difficult in the mammalian heart,
mechanistic conservation in PCP signaling allows findings from highly tractable model systems to translate
readily to PCP in mammalian systems. Drosophila is an ideal system for studying PCP due to its highly
developed genetic tools, its history as a PCP model system, and its suitability for high-resolution microscopy.
In this project, we will leverage the experimental tractability of the Drosophila model system, in combination
with cutting-edge biochemical and biophysical approaches, to elucidate the mechanistic basis for PCP
signaling. We propose two independent but interrelated Aims that will i) elucidate the feedback circuits and
molecular interactions that lead to the induction of asymmetry, and ii) determine how clustering contributes to
the amplification of asymmetry, to polarity readout, or both. To accomplish this, we will employ novel genetic
approaches to unlock understanding of extensive feedback mechanisms in PCP signaling, single-molecule
biophysical approaches that will reveal how clustering is coupled to the amplification and readout of
asymmetry, and advanced biochemical approaches that will provide direct molecular insight into how intrinsic
asymmetry in PCP complexes is achieved and into how oligomerization may result in clustering.
The proposed work will both enhance our knowledge of fundamental mechanisms underlying PCP signaling,
as well as lay the groundwork for potential therapeutic interventions for PCP-related heart pathologies.

Public health relevance
Project Narrative The long-term objective of this collaboration is to discover the essential logic and underlying molecular mechanisms that drive planar cell polarity (PCP) signaling, a highly conserved pathway that is a critical component of normal heart development. Previously applied experimental approaches have proven unable to untangle the interlocking feedback loops that are thought to underlie PCP signaling. We describe novel genetic, biochemical, imaging and computational modeling approaches that will reveal both the underlying molecular logic and mechanistic basis for this critical component of normal heart development.